Interstitial Chemophototherapy as an Intervention in Locally Advanced Pancreatic Cancer

Long-circulating liposomal irinotecan is approved for metastatic pancreatic cancer (PaCa). We developed a
modified formulation that stably integrates porphyrin-phospholipid (PoP) into the bilayer of liposomes without
exchanging with serum factors when circulating in blood. This provides for light-triggered drug delivery to
irradiated tumors, enhancing IRT delivery by an order of magnitude and inducing potent tumor regression in
multiple PaCa murine models. Our goal is to translate this concept into interstitial chemophototherapy (I-CPT)
as a tumor ablation paradigm for locally advanced PaCa. I-CPT involves image-guided placement of multiple
diffusing optical fibers into large tumors. I-CPT will be a clinically relevant approach for PaCa, as opposed to
external beam CPT which has been the basis of our studies so far.
This R01 addressing PAR-22-071 Toward Translation of Nanotechnology Cancer Interventions (TTNCI) will
advance long-circulating IRT PoP liposomes (IRT-PoP) for photoablation of large PaCa tumors models in using
clinically relevant treatment and dosimetry regimes, in combination with immune checkpoint blockade (ICB) and
advanced PaCa tumor models for assessing biodistribution and pharmacokinetics.
Pancreatic cancer (PaCa) has amongst the poorest prognosis of any cancer type, with a 5-year survival rate
of ~10%. Poor tumor perfusion contributes to the failure of conventional therapies due in large part to stromal
amplification and hypovascularity that comprise a delivery barrier that limits drug deposition. This hypovascular
environment also limits efficacy of other ablative techniques that require molecular oxygen, such as radiation
therapy and photodynamic therapy. We demonstrated that CPT dramatically overcomes poor drug delivery to
PaCa tumor models, typically delivering an order of magnitude more drug, based on mechanisms including
vascular permeabilization and drug release from the carrier. IRT-PoP CPT co-treatment with PD-1 improved
delivery to PaCa tumors leading to durable cures in mice.
In Aim 1 we will define I-CPT light dosimetry in locally advanced PaCa in preclinical models, this includes a
patient-derived xenograft model developed at Roswell Park that mimics the histological and hypovascular
features of PaCa, and an orthotopic pancreatic tumor model to allow large tumors to be treated. In Aim 2 we will
characterize IRT-PoP drug release and enhanced immunotherapy effects in an orthotopic KPC mouse model.
In Aim 3 we will use large PDX tumors in a nude rat model to model the pharmacokinetics and
pharmacodynamics of I-CPT.

Public health relevance
Locally advanced pancreatic cancer is difficult to treat, contributing to the dismal survival rate of the disease. We will translate a next-generation nanotechnology based on light-activated drug delivery by testing the approach in large advanced pancreatic tumor models in mice, rats and rabbits. We will focus on interstitial light delivery, combination with immune checkpoint blockade, and understanding the pharmacokinetics of the novel treatment.